Imaging Sciences Training Program

The Radiology and Imaging Sciences Training Program (ISTP) at the National Institutes of Health (NIH) is initiating an exciting new 1 -2 year competitive research-training program aimed at recruiting Radiologists and Nuclear Medicine Physicians, who have completed their residency training program, to the NIH to participate in translational research. The selected physicians must be motivated and capable of performing hypothesis driven research at NIH. The research training will provide the clinician the opportunity to come jump-start their academic career by focusing potentially of majority of their time at NIH on basic or clinical research. This ISTP will provide the applicants with exposure to a unique clinical research environment with translational bench-to-bedside-bench research opportunities along with access to state-of-the-art equipment, laboratory space, supplies, and funds to carry out their research. In addition, these fellows will be able to work in research laboratories mentored by the Senior Staff at the NIH. This is a unique opportunity to send your best and brightest individuals with a serious research interest to the NIH to allow them to get the training they need to becoming a productive Imaging Scientist. This individual will receive didactic training in biostatistics, Core Clinical Curriculum providing them with necessary skills to write an IRB protocol and grant writing courses. This NIH trained Imaging Scientist will acquire the necessary research skills and preliminary research data to write papers and submit for a NIH RO1. These individuals should be highly coveted by Academic Radiology Chairpersons for positions in your or other departments across the US and Canada. Moreover, by investing up front and sending your brightest residents or fellows to NIH for one to two years, your dividends will pay off by having returned to you an Imaging Scientist who could potentially have a draft of a grant application in hand by the time they leave NIH.